Administrative Core

PROJECT SUMMARY/ABSTRACT
The Administrative (ADMIN) Core will coordinate and integrate the research cores of the Indiana Center for Musculoskeletal
Health-Basic Science Research Center (ICMH-BSRC) with all center activities, will ensure effective
communication between all internal and external components, and will be responsible for arranging oversight
bodies to monitor progress and efficiency. In addition, the ADMIN Core will administer the Enrichment Program,
designed to identify and support new investigator funding, new collaborations, feasibility proposals, and innovation
initiatives. Outreach initiatives will include introducing underrepresented minorities to core technology for
musculoskeletal research and reaching out to other P30 Directors to share information in order to advance the
field as a whole. To accomplish these responsibilities, the specific aims of this core include the following: Aim 1:
Provide administrative support to the resource cores. Here, the ADMIN core will provide overall administrative
support to the program, including budget construction and management, account updates, coordination of institutional
support and scientific/project meetings, and liaison to the oversight boards. Aim 2: Provide statistical support
and data management to the resource cores. Here, the ADMIN core will provide study design consultation,
data management strategies, and statistical support services to projects supported by the resource cores and
pilot projects. Aim 3: Serve as a liaison between the ICMH-BSRC and the multitude of other relevant units on
campus to maximize interaction, synergy, and growth. Here, the Admin Core will serve as the lead contact for
ICMH-BSRC interaction with the highly fortified resource environment at IU that comprises other functional units.
Aim 4: Administer pilot grant programs that fund the use of the resource cores. Here, the ADMIN core will administer
pilot funding for new, collaborative, innovative projects that involve core usage and also funding for our pipeline/
retention programs to fortify the MSK workforce into the future. Aim 5: Provide communications, education,
and outreach for the resource cores. Here, the ADMIN core will engage in outreach to the broader community
including undergraduate and high school students, as well as other research groups around the country whose
programs would benefit from our core services. In summary, the ADMIN core will facilitate basic science research
by supporting MSK investigators, providing a roadmap of existing resources for the conduct of basic research,
and training investigators in study design, measurement techniques, methodologies, and outcome measures in
musculoskeletal science. It will serve as a critical resource that will enhance and grow basic MSK research
across Indiana and beyond.